A New Mode of Inhibition to Target Protein-Protein Interactions by Ligand-Transferred Oxidation

PROJECT SUMMARY / ABSTRACT
The overarching goal of our research group is to establish new ways to inhibit proteins, to unlock targets currently
considered undruggable, and to transcend the limitations of current medical interventions. Protein–protein
interactions remain challenging targets for conventional small-molecule therapeutics. We recently discovered
a new approach to block protein–protein interactions by arming ligands with functional groups that
transfer oxygen atoms onto methionine sidechains to block binding interfaces. Ligand-targeted oxidation
of a biomedical target protein, exploiting natural and unnatural post-translational oxidative states of sidechains
to alter a protein’s function, is unprecedented among known modes of action for therapeutics. We propose the
first study to establish the fundamentals of this new strategy, and to harness this long-lived mode of
inhibition for blocking challenging protein–protein interactions among key immuno-oncology targets.
Our research program covers multiple targets and approaches, on the common theme of sidechain oxidation,
deployed to inhibit immune checkpoint protein–protein interactions as the first case-study for this technology.
Importantly, our research program aligns with unaddressed medical needs of many cancer patients who cannot
benefit from the first-generation antibody-based immune checkpoint inhibitors. Developing ligand-targeted
oxygen transfer in this context has the potential to fulfill the long-standing goal of the scientific community to
expand immuno-oncology to fight more types of cancer, especially solid tumors and immunologically shielded
cancers. More broadly, we envision that precision-targeted oxygen transfer will enable us to inhibit many other
challenging biomedical proteins currently deemed undruggable, paving the way to address unmet medical needs
that are underserved by conventional small-molecules and antibody-based therapeutics.
CONFIDENTIAL—ALBERT EINSTEIN COLLEGE OF MEDICINE JP Maianti, Ph.D. –– Project Summary, Page 1/1

Public health relevance
PROJECT NARRATIVE Our research program will develop a new concept of precision-targeted oxidation of protein sidechains as a mechanistically innovative therapeutic modality to irreversibly block challenging protein–protein interactions. Importantly, our first application of this technology aligns with the unmet medical needs of many cancer patients, and has the potential to fulfill the long-standing goal of the scientific community to expand immuno-oncology to fight more types of cancer, especially solid tumors and immunologically shielded cancers. More broadly, this new therapeutic modality will enable us to reclassify many undruggable proteins as druggable targets, paving the way to intervene in a broad range of untapped cancer pathways and disease indications underserved by conventional therapeutic strategies. CONFIDENTIAL—ALBERT EINSTEIN COLLEGE OF MEDICINE JP Maianti, Ph.D. –– Project Narrative, Page 1/1